Impacts of Drone Distractions on Working Safety at Heights in Construction

PROJECT SUMMARY/ABSTRACT
The overall objective of this project is to investigate how the presence of a drone (visual appearance and/or flying
sound) in a construction field distracts workers at heights and impacts their working safety. Two hypotheses are
proposed. The first hypothesis is that the drone presence diverts the workers’ visual attention, so that they may
not recognize the hazards of leading edges and unguarded openings on floors as they normally can. The second
hypothesis is that the drone presence requests extra effort from the workers to keep their balance while working
at sloped surfaces. To test both hypotheses, two experiments are designed and conducted. In the first
experiment, 24 test participants are involved. Each participant is asked to wear an eye-tracking headset and pick
and place a box (7.5 kg) in virtual construction scenes under different drone flying conditions. The fixation-related
metrics, i.e., fixation time and fixation count, are calculated to measure the participant’s visual attention on the
recognition of leading edges and unguarded openings. In the second experiment, 12 test participants are
involved. Each participant is asked to mimic the shingling task on the roof simulator under different combinations
of postures, slopes, and drone interventions. The body’s Center of Pressure, Center of Gravity, and Base of
Support are used to measure the participant’s efforts on keeping balance during the shingling task. The
measurements from both experiments are further analyzed through statistical tests. This way, the quantitative
relationships between a flying drone and its impacts on distracting construction workers at heights can be
established.
These quantitative relationships will be the main outcome of this project. They will build a solid foundation to help
the occupational safety and health community create guidelines and regulations on drone use in construction
workplaces. This project is expected to contribute to addressing the NORA Construction Sector "Strategic Goal
6: Improving workplace safety to reduce traumatic injuries” with the focus on “Intermediate Goal 6.3: Injuries
related to emerging technologies (e.g., robots and exoskeletons)”. Also, the research team in this project will
collaborate with construction contractors in Wisconsin and West Virginia. Based on the results and findings from
this project, they will work together to 1) identify what policies could be taken to control the impacts of the drone-
induce distractions on construction workers, 2) transform these policies into best practices in the construction
industry, 3) assess these policies and best practices in real construction workplaces, and 4) disseminate and
share the practices disseminate and share the practices through the NIOSH Traumatic Injury Prevention
Program and/or with other construction companies to fulfill the NIOSH r2P initiative's efforts.

Public health relevance
PROJECT NARRATIVE This project investigates the impacts of drone-induced distractions on construction workers (i.e., material handling laborers and roofers) at heights. The relationships between the distraction impacts and the drone operations are quantified. The project will help to prevent fatal and non-fatal injuries related to falls, slips, and trips due to the distractions induced by emerging aerial robotics and automation technologies in construction.